Load-Dependent Arterial Stiffness to Optimize Blood Pressure Management in Older Veterans (LOADED BP)

Aims and Rationale: Hypertension is ubiquitous within the VA system and is the leading cause of preventable
cardiovascular disease in the United States. Over 1/3 of Veterans with hypertension are not treated to goal, and
there are significant differences between professional guideline statement recommendations. A critical
knowledge-practice gap exists in blood pressure (BP) management: Treatment decisions in older adults rely
mainly on brachial artery BP measurements, ignoring arterial stiffness mechanisms and the underlying genetics
of hypertension. We need non-invasive tools to identify older adults most likely to benefit from more intensive
BP targets. We plan to evaluate novel physiologic mechanistic arterial stiffness measures (load-dependent
stiffness and structural stiffness) and a known BP polygenic risk score (PRS) to improve hypertension care in
older Veterans. Total arterial stiffness (e.g., arterial wall rigidity) has two distinct components: 1) structural
stiffening due to arterial wall remodeling (e.g., elastin degradation and fibrin and collagen deposition) and 2)
load-dependent stiffness, by which elevated BP increases collagen fiber loading. We hope to use these tools to
improve our understanding of individual differences in BP treatment responses. We plan to determine if intensive
vs. standard BP treatment (i.e., <120 vs. <140 mmHg) improves arterial stiffness components (load-dependent
and structural) in older hypertensive Veterans with baseline systolic BP ≥140 mmHg) over 12 months and
determine if baseline load dependent stiffness is associated with BP response regardless of treatment group.
Finally, we will determine if a BP PRS can be used to explain individual variability in stiffness responses. A
straightforward non-invasive arterial stiffness test, like load dependent stiffness, combined with genetic markers,
could improve hypertension and CVD outcomes by personalizing treatment plans in this at-risk Veteran
demographic.
Methods: We propose a three-site randomized controlled trial that will enroll hypertensive Veterans ≥60 years
old (n=228). Participants will be randomized 1:1 to intensive or standard BP treatment (<120 vs <140 mmHg).
The primary outcomes of load-dependent and structural arterial stiffness will be assessed at baseline and after
3, 6 and 12 months of guideline-based antihypertensive therapy. Medications will be prescribed and titrated at
each visit, and serious adverse effects including hypotension, acute kidney injury and falls will be documented.
This will permit the analysis of the impact of BP treatment goals of the mechanistic components of arterial
stiffness in older Veterans (primary outcome) and improve our understanding of the underlying genetic factors
related to the individual differences in stiffness mechanisms and their specific BP response to treatment goals.
Innovation/Significance: BP control is a major unaddressed problem in the VA Health system. Load-
dependent arterial stiffness measures and a BP PRS may provide a novel way to personalize BP goals in older
adults and offer new insights into complex phenotypic and genetic differences in BP response. The interaction
between blood pressure and stiffness is well described for total arterial stiffness measures, but the impact of
standard vs. intensive blood pressure targets on both phenotypic arterial stiffness (load-dependent vs structural
stiffness) and genotypic associations with a blood pressure specific polygenic risk score (PRS) has not been
studied in older adults. This non-invasive stiffness test could be used as a novel risk-stratification tool to help
identify older patients who would benefit from the most aggressive BP treatment goals, ultimately decreasing
CVD events in this at-risk population. This will facilitate further studies that could eventually lead to the use of
these techniques in clinical settings, allowing prescribers to easily and non-invasively identify older Veterans at
the highest CVD risk and more easily assign optimal blood pressure targets to each patient.

Public health relevance
Hypertension is a common and treatable disorder that remains the leading preventable cause of cardiovascular disease. Blood pressure treatment relies mainly on brachial blood pressure readings and ignores arterial stiffness physiology and the underlying genetic information. Older Veterans with hypertension are less likely to be treated to goal blood pressure because there are conflicting recommendations for what constitutes “optimal” in this group. We have developed a novel way to assess the component of arterial stiffness that is related to blood pressure (load-dependent stiffness). This project will generate new knowledge about how different blood pressure treatment goals (intensive vs standard) impact different components of arterial stiffness and if these differences can be explained through DNA analysis. Results from this project will offer the VA a blueprint for personalizing blood pressure care in older adults, ultimately improving cardiovascular health.